Administration

The administrative support of the Cancer Center provides the focal'point for achieving "centerness", the integration that is the hallmark of a successful Cancer Center. This nebulous attribute is essential in our institution where depth and breadth of science abound. The challenge is to provide the resources and atmosphere that will induce investigators to look past their traditional departmental silos, focus their expertise on cancer and take advantage of the opportunities for collaborative research that are essential for translation from discovery to application. The leaders of the Cancer Center are responsible for creating the resources and collegia! opportunities that support this philosophy, and the staff of the Cancer Center are responsible for creating the atmosphere that attracts investigators and maintains their participation. UWCCC Administration provides support for all functions required for efficient operation of all Center activities. The total budget for the administration of the Cancer Center is $1,444,751. This proposal requests support for 29% of the operating budget. These figures do not include the cost of other institutional personnel from the UW Hospital and Clinics and UW Foundation, whose collaborative work is essential.